Mentoring in Patient-Oriented HIV Research in the Era of Universal ART

Project Summary / Abstract
The primary purpose of this K24 renewal proposal is to support mentorship by Dr. Lockman of early career
investigators from the US and Africa in conducting global patient-oriented research. This next generation of
investigators will need to tackle ongoing global infectious disease epidemics (such HIV, COVID-19,
tuberculosis, malaria, and antimicrobial resistance) and to respond rapidly to future emerging pandemics and
pathogens. Effective mentorship of early career investigators to conduct clinical research in resource-
constrained settings requires substantial time and effort by experienced mentors, and the need for such
mentors exceeds their availability. The initial K24 project period permitted Dr. Lockman to successfully mentor
more than 20 early career investigators (half of them from Africa) to lead clinical research projects, many of
whom were able to quickly respond to the severe COVID-19 epidemic in Botswana because of prior training.
This K24 grant also allowed Dr. Lockman to gain additional skills in designing and conducting patient-oriented
research in resource-constrained settings with a focus on HIV (particularly in pregnancy) and COVID-19.
Currently, nearly one in five adults in many sub-Saharan African countries is living with HIV; the impact of HIV
co-infection on COVID-19 clinical outcomes and on SARS-CoV-2 viral evolution in settings with both very high
HIV prevalence and high COVID incidence are unknown. In addition, the impact of widely used HIV
antiretroviral treatment (ART) regimens during pregnancy on birth outcomes and on long-term maternal and
child health and development are not well understood. The research aims of this project, which Dr. Lockman
will mentor early career investigators from Africa and the US to lead, include studies of the role of HIV co-
infection in several aspects of SARS-CoV-2 infection in Botswana -- specifically, the impact of HIV infection on
long COVID and on the emergence of SARS-CoV-2 mutations/variants, by SARS-CoV-2 vaccination status.
Additional mentored aims will evaluate the impact of different ART regimens during pregnancy on
cardiometabolic factors in women (specifically, pregnancy and postpartum weight gain, and markers of
diabetes and metabolic syndrome in pregnancy), and the association between these cardiometabolic factors
and pregnancy outcomes and child health/growth. Dr. Lockman’s mentees will use existing data and samples
for these aims, including from studies that she leads (multi-country IMPAACT 2010/VESTED randomized trial
of 3 ART regimens in pregnancy and a new R01-funded study of child developmental/behavioral outcomes
after in utero exposure to different maternal ART regimens in Botswana) and from stored clinical SARS-CoV-2
samples and related electronic routine health databases in Botswana. Dr. Lockman will also help her mentees
access a wealth of other existing data, resources, and co-mentors. The overarching goal of this K24 renewal
proposal is to help expand sustained capacity to conduct high-impact patient-oriented research in Africa by
supporting the mentorship and training of early career investigators.

Public health relevance
Project Narrative The primary purpose of this proposal is to support ongoing mentorship of early career investigators in conducting patient-oriented research related to HIV and other infections (with a partial focus on pregnancy). The ultimate goal is to expand and strengthen the expertise and capacity of young researchers for performing this research and to answer clinical questions of public health importance, in order to enhance the health of Americans and of people worldwide. Key research aims are to study the impact of different HIV treatment regimens during pregnancy on cardiometabolic risk factors in women and their role in pregnancy and maternal health outcomes and child health and growth (including pregnancy and postpartum weight gain, child growth, and markers of diabetes and metabolic syndrome in pregnancy).